Meeting South African adolescent girls and young women who experience intimate partner violence where they are: Developing an implementation strategy for linkage to PrEP options

PROJECT SUMMARY
Intimate partner violence (IPV) is a serious public health concern affecting adolescent girls and young women
(AGYW) in South Africa, with a cumulative incidence of physical or sexual IPV among AGYW aged 15-19
years of 37%. IPV is also a significant contributor to the HIV epidemic among women globally and in South
Africa, where young women with violent or controlling male partners are 1.5 times as likely to acquire HIV.
Biomedical HIV prevention options that do not require participation from both partners, such as antiretroviral
pre-exposure prophylaxis (PrEP), are critical. Further, providing options for approved long-acting PrEP (LA-
PrEP) modalities, including the dapivirine ring and long‐acting injectable cabotegravir (CAB-LA), for AGYW
who perceive barriers to daily oral PrEP use, may provide IPV-exposed AGYW in South Africa with greater
agency over their sexual health. Pathways for entry to PrEP care from existing public health touchpoints that
engage with AGYW who report experiencing IPV (e.g., rape crisis centers, centers for women and children) are
not currently available. However, integrating discussions surrounding HIV prevention into existing IPV care can
ultimately serve a population experiencing intersectional stigma to address both IPV and HIV risk. The current
project proposes to conduct formative work to develop a multi-component implementation strategy to link
South African AGYW who experience IPV with PrEP options, including LA-PrEP. Guided by the Exploration,
Preparation, Implementation, Sustainment framework and the Health Belief Model, this study aims to conduct
qualitative in-depth interviews and a brief cross-sectional survey among IPV-exposed AGYW (AIM 1) and key
informants (AIM 2), including potential program implementers and policymakers, to investigate 1) knowledge
and opinions of PrEP; 2) preferences for approved PrEP modalities (e.g., oral PrEP, the dapivirine ring, and
CAB-LA); 3) perceived barriers/facilitators to PrEP uptake and adherence among IPV-exposed AGYW; and 4)
inner and outer setting factors influencing PrEP delivery. Participants will be asked about barriers/facilitators to
PrEP uptake, adherence, and delivery relative to evidence-based PrEP-linkage strategies (e.g., providing
education and/or training, placing a peer navigator at touchpoints, care integration), and suggestions for novel
strategies will also be explored. Additionally, we will probe participants to discuss the role that stigma may play
in PrEP implementation to inform potential resilience resources that can be incorporated into the strategy. This
formative work will be used in AIM 3 to develop a multi-component PrEP-linkage implementation strategy
through iterative consultation with established community advisory board members, including AGYW, local
community members, advocates, service providers, and other key stakeholders (AIM 3), that will be tested in a
future pilot trial. In summary, this research aims to respond to AGYW in a generalized HIV epidemic setting
who are experiencing IPV by optimizing the implementation of approved PrEP modalities. Findings will
ultimately contribute to knowledge on biomedical HIV prevention implementation among priority populations.

Public health relevance
PROJECT NARRATIVE Intimate partner violence (IPV) is an important contributor to the HIV epidemic among women globally, and identifying and responding to women in generalized HIV epidemic settings who experience IPV is an important HIV prevention strategy. Given the high burden of both IPV and incident HIV among AGYW in South Africa, biomedical HIV prevention options that do not require participation from both partners, such as HIV antiretroviral pre-exposure prophylaxis (PrEP), are critical. This research aims to guide the implementation of approved PrEP modalities among IPV-exposed AGYW in South Africa, which will have important implications for biomedical HIV prevention implementation among priority populations globally.